In Vitro Assessment for Antimicrobial Activity Support (Task Area B)

This contract provides in vitro testing of potential antimicrobial agents, maintenance of stocks and cell lines, development of related assays and new techniques to culture difficult to grow pathogens.